FOURTH INTERNATIONAL CONFERENCE ON MONOCLONAL ANTIBODY

The proposed conference is our fourth conference devoted to monoclonal antibody conjugates for clinical use in cancer. Leading researchers from around the work will present the latest results of their clinical trials in man using monoclonal antibodies linked to isotopes, drugs, and toxins for cancer therapy and detection. The program will consist of three half-day topic sessions devoted to isotope, toxin and drug conjugates; a half-day session devoted to posters and workshops; and a half day mini-symposium on the topic of the human anti-immunoglobulin response. Each topic session will begin with an overview of the field and current status of clinical trials, followed by the presentation of proffered abstracts describing recent clinical and pre-clinical data. The mini-symposium will consist of several invited speakers and presentation of proffered abstracts. This conference will be of interest to tumor immunologists, biotechnologists, medical oncologists, radiation therapists, nuclear medicine physicians and other Interested health professionals and researchers working in this field.